Improving adherence to posttreatment follow-up care for rural lung cancer survivors through a community-clinical survivorship care team model

Project/Summary: Rural lung cancer survival rates have lagged behind the national average for decades. A key
contributor to recent survival disparities is fragmented survivorship care, leaving rural survivors without supports
to facilitate survivorship care and adherence to follow-up care. Rural survivors often receive their care from
specialists located in distal, urban centers, where travel, social, and financial burdens threaten adherence to
follow-up care. Further, urban healthcare professionals are unaware of rural resources and encumbered by
finding rural community resources needed to overcome barriers to care. Thus, a community-clinical survivorship
care team is a promising strategy to improve timely follow-up care and provide linkages to community resources.
A rural community health worker (CHW) that is knowledgeable about local resources and the socio-economic
barriers to survivorship care is a fitting community agent on a community-clinical team. The success of
community-clinical care teams to improve care coordination and health outcomes is well documented, but few
of these studies investigate rural survivorship care or the integration of a CHW in the team model. Also, a gap in
the literature exists regarding the implementation of a CHW-clinical survivorship care team model to improve
rural survivorship outcomes. To address this critical gap, the research examines the implementation of a CHW-
clinical survivorship care team to improve adherence to follow-up care for rural lung cancer survivors. The aims
of this project are to 1) assess perspectives on desired CHW roles and their processes for interacting with clinical
care team members in a community-clinical survivorship care team; 2) test the feasibility and initial acceptability
of CENTRAL, and 3) evaluate the implementation of CENTRAL to identify factors that influence its sustained
use in a multi-site effectiveness-implementation trial design R01. CENTRAL will be adapted from an existing
patient navigation research program, and interviews with key stakeholders to inform CHW roles and processes
for working with clinical care teams (Aim 1). Dr. Lewis-Thames will pilot CENTRAL (N=60) with rural lung cancer
survivors to assess its acceptability and feasibility (Aim 2). Aim 3 will provide insights on facilitators and barriers
of implementing CENTRAL via the EPIS (exploration, preparation, implementation, sustainment) implementation
framework through an analysis of implementation costs and interviews with CENTRAL participants, CHWs and
providers. This K01 involves a training plan consisting of coursework, seminars, experiential learning, and
mentorship by an established team of experts. The research is conducted at Northwestern University and
affiliated rural-serving Cancer Centers which offer superior facilities and resources to provide training in
intervention development and adaption, implementation science, cost-analysis, and rural survivorship care. The
outlined training plan will enable Dr. Lewis-Thames to accomplish her long-term career goal to become an
independent cancer disparities implementation. The proposed project is relevant to the NCI's Division of Cancer
Control and Population Science research emphasis on rural cancer control and health disparities.

Public health relevance
Project Narrative: Rural community health workers embedded in clinical survivorship care teams—CHW-clinical survivorship care teams—is a strategy to improve fragmented rural survivorship care, adherence to follow-up, and facilitate linkages to local resources to overcome socio-economic barriers to care. This project will examine the feasibility, acceptability, and implementation of a pilot telehealth CHW-clinical survivorship care team intervention focused on resource referrals and connections, symptom management between follow-up care visits, and improving adherence to post treatment follow-up care recommendations of lung cancer survivors from rural areas. This research will contribute to the lack of literature addressing the implementation of survivorship care models to improve rural survivorship outcomes and eliminate disparities in rural-urban survival rates.